Tobacco Packaging and Labeling Policies: Expanding the Evidence on Novel Policies

The primary goal of Project 2 is to build the evidence base in the area of tobacco packaging and labeling policies (Article 11 of the FCTC), in low, middle, and high income countries. Project 2 will complement the survey data described in Project 1 by collecting information directly from tobacco packages and by conducting experimental studies in

Public health relevance
RELEVANCE (Seeinstructions): Health warnings and tobacco labelling policies have been identified by the WHO as one of six critical policies to address the tobacco epidemic. This project will collect information in high, middle, and low income countries to address key gaps in the evidence, particularly in low and middle income countries.